Specialist in Multi-Scale Molecular Imaging of Tumor Environments

Cancer cells exhibit remarkable heterogeneity in cell signaling, metabolism, and other functional
states. Changing environmental conditions impose additional stresses on cancer cells, further
increasing tumor heterogeneity as subsets of cells reprogram key functions to survive,
disseminate, and ultimately produce metastases. Tumor heterogeneity and adaptations of cancer
cells emerge dynamically over the course of tumor progression and treatment, underscoring the
critical need to analyze cancer cells over space and time. As an expert in molecular imaging,
cancer model systems, and cancer biology, I develop approaches to quantify key processes in
cancer biology, including signaling, metabolism, and pharmacodynamics of therapy, in complex
living systems from cell-based assays to animal models. My expertise in fluorescence and
bioluminescence imaging makes me uniquely qualified to accomplish these goals. I am a pioneer
of in vivo bioluminescence imaging of biochemical events, having invented firefly luciferase
complementation. I remain at the forefront of developing new bioluminescence methods for
discovery in cancer. I have a strong record of engineering new reporters and implementing
methods to extend capabilities of in vivo multiphoton microscopy, both with multiplexed
fluorescence imaging reporters and fluorescence lifetime imaging. To capture tumor
heterogeneity from imaging data, I write custom image processing code to automatically segment
and quantify multiple imaging reporter signals from thousands of cells. My effort is fully funded by
3 NCI research programs. 1) Integrators of Metastatic Potential: Discover how GIV, a signaling
hub for multiple signaling pathways, drives programs necessary for metastasis-initiating cells; 2)
Imaging Disease Heterogeneity and Response to Therapy in Myelofibrosis: Develop novel
imaging methods to analyze the bone marrow environment and pharmacodynamics of therapy in
myelofibrosis and other myeloproliferative neoplasms; and 3) University of Michigan Quantitative
Co-Clinical Imaging Research Resource: Establish and standardize quantitative imaging methods
for co-clinical trials using established and investigational therapies for myelofibrosis. These
projects are dynamic, productive multidisciplinary collaborations involving me, the Research
Director (Dr. Gary Luker, MD), and a network of exceptional investigators in oncology, cancer
biology, cell signaling, and imaging. My multidisciplinary expertise and experience allow me to
effectively bridge the gap that may exist among scientists and trainees from disparate scientific
fields. This award will enable me to continue interdisciplinary molecular imaging research focused
on understanding and overcoming tumor heterogeneity to advance precision medicine in cancer.

Public health relevance
Cancer cells reprogram signaling, metabolism, and other functions in response to changing environmental conditions. Understanding how malignant cells adapt to environmental stresses requires the ability to analyze cancer cells in real time in physiologic settings. I develop new imaging methods to visualize and quantify functions of cancer cells in tumor environments, providing information and technologies needed to better prevent and treat primary and metastatic cancer.